Chemical Synthesis Shared Resource

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
CHEMICAL SYNTHESIS SHARED RESOURCE - PROJECT SUMMARY/ABSTRACT
The Chemical Synthesis Shared Resource (CSSR) enables novel chemical synthesis to MECC researchers who
do not have the facility to create novel molecules in their own laboratories. In this role, the CSSR offers a broad
spectrum of chemical synthesis, medicinal chemistry, computational chemistry, analytical chemistry, chemical
reactivity and chemical identification services for unknowns. CSSR provides consulting and project planning with
a particular focus on project planning for research grant applications. Data evaluation for the use of CSSR
compounds, editing and publishing support is provided as part of the service to members of the MECC. CSSR
is equipped with state-of-the-art instrumentation to perform complex chemical reactions including, low
temperature, photochemical, chiral synthesis, organometallics, carbohydrates, peptides, pressure reactions,
isotopic labeling, and microwave-stimulated chemistry. CSSR services in chemical synthesis are custom-tailored
to solutions for each MECC investigator. From simple reagent synthesis of a reference compound to
collaboration throughout an entire project, CSSR provides chemical validation from the grant application to the
published work. All chemical needs and problems are addressed on the level of the individual investigator.
The main specific aims are as follows:
Aim 1. Provide high quality chemical synthesis expertise to MECC researchers by planned interactions between
MECC researchers and resource personnel.
Aim 2. Provide expert project-related chemistry for grant and proposals and publications.
Aim 3. Develop and expand ligand screening capacity for novel targets of the MECC research community. Curate
and expand, as needed, the click-chemistry (Copper catalyzed azide-alkyne cycloaddition, SuFEx) library within
the CSSR for use in novel cancer targets. Develop screening protocols and reagents for applying the new
technology of SuFEx targeting discovery. Incorporate computational virtual screening as leads to new chemical
compound synthetic targets within the CSSR.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward CHEMICAL SYNTHESIS SHARED RESOURCE - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page